ANTIBODY &ANTIGEN INTERACTIONS

Analysisof MRI contrast agents targeting for receptors found on tumors of epithelial orgin. IR dyes will be monitored as they accumulate in tumors grown in rats and transgenic mice.